Massachusetts Eye and Ear/ Harvard Initiative for the NIDCD National Human Ear Resource Network

Project Summary
This proposal to join the NIDCD National Human Ear Resource Network pools the skills of an international
consortium of researchers with decades of experience in the histopathological study of acquired and hereditary
disorders of hearing and balance, and in the curation of one of the largest collections of human temporal-bone
(TB) specimens in the world. Because the ear cannot be biopsied, and non-invasive imaging cannot yet
provide cellular level resolution, insight into the pathologies underlying deafness and balance disorders derives
from the study of TBs removed at autopsy, which classically have been decalcified, plastic-embedded and
serially sectioned, with a subset then stained with hematoxylin and eosin (H&E) for pathological study.
In Aim 1, we continue to accrue and process human TBs, document the histopathology and
medical/otologic history, and upload the de-identified data to a searchable database, along with digitized
images of all the H&E-stained slide sets, to jumpstart more widespread collaborations in the study of human
otopathology. We will also continue to distribute unstained sections from our TB archives to researchers for
additional morphological, molecular biological or genetic studies of particular disorders.
In Aim 2, we enhance techniques for human TB study in three key ways: first (Aim 2a), by perfecting a
novel approach to embedding (methyl methacrylate) and sectioning (laser microtomy) that is cheaper and
faster than celloidin, allows morphological and chemical analysis of undecalcified bone and otoconia, and is
less destructive to protein and RNA/DNA; second (Aim 2b), by pursuing the ex vivo imaging of intact
cochleas via high-resolution x-ray tomography, enhanced by coupling celltype-specific immunomarkers to
heavy metals and by developing software to automate extraction of quantitative histopathological data from
these 3D image stacks; and third (Aim 2c), by developing and applying techniques for DNA extraction and
whole-exome sequencing from donor tissue samples and/or celloidin TBs, to identify the pathogenic variants
responsible for the numerous hereditary hearing loss cases in our archives that were not genotyped during life.
In Aim 3, we strive to accelerate the pace of discovery in human otopathology by sponsoring fellowships,
organizing national symposia and by creating and disseminating training materials, via hands-on courses,
online tutorials, technical manuals on the classic and novel techniques needed for the procurement, processing
and histopathological analysis of human temporal bones.

Public health relevance
Project Narrative - Public Health Relevance To speed the development of therapies for inherited or acquired disorders of hearing and balance, we need to better understand the patterns of cellular damage and molecular disorder associated with each different etiology. Because the ear cannot be biopsied, and non-invasive imaging cannot yet provide cellular or molecular level resolution, all of our insights into the pathologies underlying deafness and balance disorders derive from the study of post-mortem specimens of the human temporal bone, which houses the structures of the external, middle and inner ears. This proposal, to join a national network of laboratories devoted to the study of the human temporal bone, seeks to increase the relevant knowledge base by continued accrual and study of new autopsy specimens, distribution of these specimens to other collaborating laboratories, development of new state-of-the-art techniques to extract cellular and molecular information about temporal bone pathology, and train the next generation of researchers and technicians in the art and science of temporal bone study.